Maryland Population Research Center

PROJECT SUMMARY
This application requests a fourth consecutive five-year cycle of NICHD Population Research Infrastructure
Program support to the Maryland Population Research Center (MPRC) at the University of Maryland (UMD).
The MPRC is an interdisciplinary center at the University of Maryland-College Park that supports the research
of 82 population researchers across 6 different schools or colleges and 16 departments. Over the next five-
year period, MPRC will support the Primary Research Areas of Gender, Family, and Social Change, Social and
Economic Inequality, Health in Social Context, and Migration and Immigrant Processes, and will support
innovations in data and methods for population research across these substantive areas. This support will be
provided by three cores that are central to increasing the pace and impact of population science research:
Administrative, Scientific and Technical, and Development. Their missions are to meet the infrastructure needs
of population scientists, to foster an interdisciplinary intellectual environment, and to promote the development
of junior and underrepresented minority scholars in population research. The Administrative core will support
the preparation of grant applications, post-award project management, and will assist other cores. It will deploy
web-based tools to enhance Center activities and will provide scholars effective means of managing research
collaborations and disseminating research. The Scientific and Technical Core will manage the computing
resources, provide confidential data access including the National Survey of Adolescent to Adult Health, and
will provide statistical computing short courses and consulting, all vitally supporting empirically-focused
population research. The Core will also expand associates’ research using restricted data access across the
federal statistics agencies by participation in the leadership of, and sponsoring symposia on the use of data
within, the new Federal Statistics Research Data Center (FSRDC) recently established at UMD. The
Development Core will promote the intellectual community of population research at UMD through seed grant
programs and by organizing a weekly seminar series, workshops, and by organizing and co-sponsoring
conferences and symposia. The Core also supports resident population scientist and visiting population
scientist programs that provide a primary institutional and physical home for population researchers
permanently and temporarily based at UMD. Taking advantage of our location in the Washington, DC area,
MPRC will promote the research of our associates through linking to the research and data activities of federal
agencies in the Washington, D.C., including through support to biennial workshops and conferences on time
use research using the American Time Use Survey and its international counterpart surveys. Infrastructural
support for data collection encompasses the large-scale survey research of the India Human Development
Survey through to smaller-scale data collections on the reproductive health among women in Delaware and on
kin support to low-income single mothers in Nairobi.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) The MPRC promotes research that is central to the NICHD Population Dynamics Branch mission, in areas of demographic research, population and health, and reproductive health and HIV/AIDS research.